Structural mechanisms of sliding clamp loader ATPases

All life forms require a ring-shaped sliding clamp to coordinate replication of their genome. These
sliding clamps act as master regulators of DNA replication, coordinating replisome action with
other cellular processes. These master regulators are themselves regulated by large ATPase machines
called clamp loaders that either install or remove sliding clamps from DNA. This project seeks to
gain an atomic-level understanding of clamp loader mechanism. These protein remodeling machines
open the sliding clamp ring as a key step in their action. We have found that in the key
intermediate complex—consisting of an open clamp, an ATP-bound clamp loader and the target DNA—the
protein components form an open spiral that matches the helical symmetry of DNA. This symmetric
spiral activates ATP hydrolysis leading to clamp closure and release of the loaded clamp. In Aim 1,
we now turn our attention to the critical first two steps of the reaction: the opening of the clamp
and the binding of DNA to the inner chamber of the complex. We will identify the conformational
changes in the clamp loader complex that allow for opening the clamp ring, as well as how the
assembly can rapidly bind a specific DNA structure in the tight confines of the complex's interior.
In Aim 2, we investigate how the single subunit change in the clamp loader complex (Rfc1 replaced
with Elg1) converts a dedicated clamp loader into a dedicated unloader. This work will not only
reveal the mechanism and structure of a key protein involved in cancer development, but will also
provide a blueprint for how an ATPase machine can be reprogrammed to perform a reverse reaction.
Finally, in Aim 3 we explore how replacement of the Rfc1 subunit with the Ctf18 protein leads to an
assembly that is bifunctional as both a loader and unloader, and that connects DNA replication to
the process of sister chromatid cohesion. Our structures and analysis of this complex will reveal
how an ATPase machine can be mechanistically flexible to catalyze both forward and reverse
reactions. In addition, this work will provide insight into how this mysterious complex can link
the seemingly disparate processes of DNA replication and sister chromatid cohesion. Because clamp
loaders and sliding clamps are fundamental to all life, the structural insights that we obtain from
completing our aims will be used for developing novel antimicrobial or chemotherapeutic drugs.

Public health relevance
Project Narrative Sliding clamps are proteins that are critical to the copying of DNA. These ring-shaped proteins are installed or removed from DNA by clamp loaders. Sliding clamps and clamp loaders are important for cellular proliferation and cancer development. We will uncover how sliding clamps are put onto or removed from DNA. We will determine these processes in atomic detail. This work will provide an understanding of how nature’s nanomachines have evolved to do mechanical work, and will also provide a blueprint for how to target sliding clamp loaders for chemotherapy or antimicrobial therapy.